Insulin regulation of hepatic transport

PROJECT SUMMARY
Transport of bile acids from blood through the liver into the bile is a fundamental part of the enterohepatic
cycle. Efficient transhepatic transport prevents cytotoxic effects of bile acids, and is critical for human health.
We have unexpectedly found that insulin, a hormone long known as a chief orchestrator of postprandial
metabolism, promotes hepatic bile acid transport. We have now shown that this occurs in humans, mice, and
sandwich cultured murine hepatocytes, a polarized in vitro model of hepatic transport. Moreover, we find that
obese, insulin resistant humans and mice have impaired hepatic bile acid transport, and this can be reversed
by weight loss. In this grant, we propose to determine the underlying biology of this pathway: Through which
upstream signaling mechanisms does insulin regulate bile acid transport? Which distal mediators of bile acid
transport are ultimately employed to carry out insulin’s effects? Which aspects of this pathway are disrupted in
obesity/insulin resistance? Does this pathway affect all bile acids? Is the effect specific to bile acids, or does it
broadly affect canalicular secretion? We will use gold-standard bile acid kinetics studies, hyperinsulinemic-
euglycemic clamps, state-of-the-art mass spectrometry, unique sandwich cultured hepatocyte models, and
tissue-specific knockout mice. Success of this work is expected to elucidate a fundamental effect of insulin on
hepatic function and postprandial nutrient handling.

Public health relevance
PROJECT NARRATIVE Bile acids, which are important for promoting fat digestion in the intestine, are made in liver and circulate repeatedly between liver and intestine through the bile and the blood. The transport of bile acids must be tightly controlled, because excess levels of bile acids in blood or tissues can be toxic. We have found that bile acid transport is regulated by the hormone insulin, and this grant is designed to determine how this regulation occurs.